Multilevel Community-Based Mental Health Intervention to Address Structural Inequities and Adverse Disparate Consequences of COVID-19 Pandemic on Latinx Immigrants and African Refugees

PROJECT SUMMARY
The goal of this study is to test a multilevel approach to reduce adverse consequences of the COVID-19
pandemic with disparate impacts on Latinx and Black immigrants and refugees by observing and implementing
three nested levels of intervention: 1) an efficacious 6-month peer advocacy and mutual learning model
(Refugee and Immigrant Well-being Project, RIWP); 2) engagement with community-based organizations
(CBOs); and 3) structural policy changes expected to be enacted in response to the pandemic, such as a state
disaster relief proposal for mixed status Latinx families and expanded statewide health insurance coverage.
This community-based participatory research (CBPR) study builds on a long-standing collaboration with five
community-based organizations (CBOs) that focus on mental health, education, legal issues, and system
change efforts to improve the well-being of Latinx immigrants and African refugees. By including 240 Latinx
immigrants and 60 African refugees recruited from CBO partners who are randomly assigned to treatment-as-
usual CBO involvement or the RIWP intervention and a random sample comparison group of 300 Latinx
immigrants, this mixed methods longitudinal waitlist control group design study with seven time points over 36
months will test the effectiveness of the RIWP intervention and engagement with CBOs to reduce
psychological distress, daily stressors, and economic precarity and increase protective factors (social support,
critical awareness of/access to resources, English proficiency, cultural connectedness, and mental health
service use). This study will also test the ability of the RIWP intervention and engagement with CBOs to
increase access to the direct benefits of structural interventions (local/state relief-related policies) for Latinx
and Black immigrants and refugees. Mechanisms of intervention effectiveness will be explored by testing
mediating relationships between primary outcomes and protective factors. We will also track local/state policy
changes and obtain preliminary quantitative estimates of effects of these structural interventions on
psychological distress, stressors, and economic precarity using propensity score matching. Qualitative
interview data from a purposive subsample of participants and CBO staff will enable additional exploration of
mechanisms of change, the effects of policy interventions on individuals, how CBOs contribute to enacting
policies and helping people benefit from them, and the context of RIWP implementation at each site. This
research is innovative and significant because it employs cutting-edge research design and intervention
strategies to advance the science of multilevel mental health interventions that aim to understand and address
underlying structural inequities and resulting mental health disparities that have been highlighted and
exacerbated by the pandemic. Thus, this study will contribute not only to reducing the disparate adverse
mental health, behavioral, and socioeconomic consequences of the COVID-19 pandemic but also to our ability
to eliminate mental health disparities among Latinx and Black populations.

Public health relevance
PROJECT NARRATIVE This study tests the effectiveness of a community-based peer advocacy, mutual learning, and social support intervention (Refugee and Immigrant Well-being Project) to reduce several negative consequences of the COVID-19 pandemic that are disproportionately impacting Latinx and Black populations: psychological distress, financial problems, and daily stressors. In partnership with five community-based organizations that focus on mental health, legal, education, and youth issues with Latinx immigrants and African refugees, we will also be able to examine the effects of people’s involvement with community-based organizations and local and state policy changes on their mental health, economic stability, stressors, and social support. This is important not only for Latinx and Black populations and the large number of immigrants and refugees in the United States and worldwide, but also because the intervention model and what we learn from this study have the potential to alleviate mental health disparities experienced by other marginalized populations who face unequal access to social and material resources, disproportionate exposure to trauma and stress, and worse consequences of the COVID-19 pandemic.